IQGAP1 in tumorigenesis

During the fiscal year, we accomplished the following: 1. Using all atom molecular dynamics simulations, site-directed mutagenesis, and Western blotting, we unraveled the detailed mechanisms of Cdc42 and Rac1 interactions with IQGAP2. We observed that Cdc42 binding to the Ex-domain of GRD of IQGAP2 (GRD2) releases the Ex-domain at the C-terminal region of GRD2, facilitating IQGAP2 dimerization. Cdc42 binding to the Ex-domain promoted allosteric changes in the RasGAP site, providing a binding site for the second Cdc42 in the RasGAP site. Of note, the Cdc42 insert loop was important for the interaction of the first Cdc42 with the Ex-domain. By contrast, differences in Rac1 insert-loop sequence and structure precluded its interaction with the Ex-domain. Rac1 could bind only to the RasGAP site of apo-GRD2 and could not facilitate IQGAP2 dimerization. Our detailed mechanistic insights help decipher how Cdc42 can stimulate actin polymerization in metastasis. 2. PI3K (Phosphatidylinositol 3-kinase ) is a key lipid kinase in the PI3K/Akt pathway. Its frequent oncogenic mutations make it a primary drug target. Calmodulin (CaM) activates PI3K independently of extracellular signals, indicating a significant role in oncogenic PI3K activation. Here, we reveal the atomic-scale structures of CaM in complexes with the nSH2 and cSH2 domains of the regulatory p85 subunit of PI3K, and illustrate how CaM activates PI3K by targeting the soft 1-5-10 CaM-binding motifs in both the nSH2 and cSH2 domains of p85. Experimental data reveal that CaM binds cSH2 first, followed by nSH2 binding hours later. CaM typically prefers binding helical peptides. Here we observe that unlike in cSH2, the CaM-binding motif in nSH2 populates a mixed -sheet/-helix/random coil structure. The population shift from a -sheet toward CaMs favored -helical conformation explains why the nSH2 domain needs a longer time for CaM binding in the experiments. The soft CaM-binding motifs in both nSH2 and cSH2 domains establish strong CaM-PI3K interactions, collectively facilitating PI3K activation. This work uncovers the structural basis for CaM-driven PI3K activation. 3. Developed an approach using tandem mass spectrometry (MS/MS) to rapidly identify and classify multiple microorganisms. Rapid and accurate identification of microorganisms is important for public health and safety. We demonstrated, using 226 MS/MS publicly available data files (each containing from 2500 to nearly 100,000MS/MS spectra) and 4000 additional MS/MS data files, that the updated workflow can correctly identify multiple microbes at the genus and often the species level for samples containing more than one microbe. The proposed workflow computes accurate statistical significances, i.e., E values for identified peptides and unified E values for identified microbes. Our updated analysis workflow MiCId, a freely available software for Microorganism Classification and Identification, is available to interested investigators.